Role of Mettl3-dependent RNA m6A dysregulation in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
As a complex and multifactorial disease, a combination of genetics, environmental and lifestyle factors affect
ones’ risk of developing AD through complex transcriptional and translational changes in the gene
expression in AD brain, however, the mechanisms underlying these changes remain elusive. Analogous to
DNA and histone modifications, RNA modifications could also lead to alterations in gene expression which
allows extra layers of regulation of gene expression. N6-methyladenosine (m6A) is the most common internal
modification in eukaryotic mRNAs which regulates RNA stability, processing, localization, translation. It is
involved in various biological processes including mitochondrial function, synaptic function and cognitive
function, but the potential role of RNA m6A modification in aging and age-related neurodegenerative
diseases including AD is largely unexplored. Studies from my group and several other groups demonstrated
METTL3-m6A dysregulation is an early event during the course of AD. METTL3 knockdown in the
hippocampus caused AD-related cognitive deficits and neurodegeneration while METTL3 overexpression
rescued AβO-induced neuronal/synaptic and cognitive/behavioral deficits, suggesting a critical role of
METTL3-m6A dysregulation in the pathogenesis of AD. mRNA of many AD-related genes contain m6A
suggesting that METTL3-dependent m6A modification likely have impacts on multiple aspects related to AD.
Given that mitochondrial dysfunction plays a critical role in the pathogenesis of AD, it is of particular interest
to note that methylation profiling identified multiple m6A sites in mRNAs of key regulators of mitochondrial
functions including those involved in mitochondrial biogenesis (i.e., PGC1α and TFAM) and mitochondrial
dynamics (i.e., Mfn2 and DLP1). Indeed, METTL3 knockdown caused mitochondrial fragmentation and
dysfunction likely through modulation of PGC1α and Mfn2 expression which could contribute to Aβ
oligomers-induced mitochondrial dysfunction. Based on these studies, we hypothesized that reduced
METTL3-m6A signaling modulates the expression of mitochondrial regulators and contributes to
mitochondrial dysfunction and the pathogenesis of AD. Therefore, METTL3 overexpression rescues
m6A signaling and mitochondrial gene expression and function and alleviates AD-related deficits.
We will determine the mechanisms underlying METTL3 reduction in AD and explore whether and how
reduced METTL3 mediates toxic effects of AβO on mitochondrial biogenesis/dynamics and function in AD.
Novel animal models with METTL3 overexpression in the forebrain will be crossed with AD transgenic mouse
models and carefully characterized. The successful completion of this study will provide novel mechanistic
insights into changes in gene expression in AD and will likely establish METTL3-m6A signaling as a
promising therapeutic target for drug development in AD, which also have implications of studying other
neurodegenerative disorders and aging in general.

Public health relevance
PROJECT NARRATIVE METTL3-m6A dysregulation demonstrated in AD patients and in both in vitro and in vivo models suggested a critical role of reduced METTL3-m6A signaling in the regulation of key pathways involved in AD. In this application, we proposed to investigate the molecular mechanisms underlying METTL3-m6A dysregulation in AD and contribution of reduced METTL3-m6A to AD pathogenesis with a focus on mitochondrial dysfunction, as well as neuroprotective effects of METTL3 overexpression in animal models of AD which will likely establish METTL3-m6A signaling as a promising therapeutic target for AD.